Novel approaches to humanized skeletal muscle in pig

PROJECT SUMMARY
The overall objective of this Phase 1 research proposal is to significantly enhance the
efficiency of generating human skeletal muscle in pig. The economic burden related to trauma and
injury in the US is estimated at $400 billion annually. Skeletal muscle comprises ~40% of the body’s mass
and contributes to locomotion, thermoregulation, and whole-body metabolism and, therefore, the loss of
skeletal muscle due to surgery, deep burns, or injury is associated with immobility and an increased risk of
all-cause morbidity and mortality. Effective therapies do not exist. Our goal is to develop novel regenerative
therapies by generating human skeletal muscle in pig for reconstructive and transplantation based
surgeries. Our early stage prototype, using somatic cell nuclear transfer (SCNT; cloning) and blastocyst
complementation provides proof of concept for the feasibility of our platform and patented technology. With
this patented technology, we have produced viable and normal intra-species chimeras and have further
proven our ability to produce human skeletal muscle in mid-gestational embryos as well. Our surgical team
has substantial expertise in muscle reconstruction following oncological procedures and military injuries.
The problem: While our publications indicate the importance and feasibility of this platform approach,
the process of SCNT is inherently inefficient, labor intensive, and technically demanding all of which limits
the efficiency of muscle production. Furthermore, the generation of viable and normal offspring is
challenged by abnormalities that result from failures in epigenetic reprogramming, cell cycle synchronies,
chimerism, and low pregnancy rates.
Our solution: In recent years, there have been numerous reports of direct CRISPR-based editing
of zygotes produced by in vitro fertilization (IVF). This technique has been demonstrated to be highly
efficient yet whether zygote gene editing can be combined with complementation strategies in porcine
zygotes is unknown. Here, we will develop a platform for the production of intra- and inter-species chimeras
using zygote gene editing together with blastocyst complementation.
Our hypothesis: We hypothesize that zygote editing will allow for the production of significantly
greater numbers of robust embryos, which will ultimately yield a significantly greater number of
complemented embryos that will result in viable and healthy offspring with human muscle. We predict that
zygote editing and embryo complementation will provide a transformational platform for the production of
human skeletal muscle for the treatment musculoskeletal disorders and injury.
Impact: The ability to generate large quantities of mature, human skeletal muscle holds
unprecedented potential for transforming the care of patients with severe musculoskeletal injury and
disease.

Public health relevance
PROJECT NARRATIVE This research project seeks a dramatic improvement in the efficiency and production of human skeletal muscle in pig that will ultimately be used to treat patients with volumetric muscle loss. The overall goal is to improve the speed, the production and the economic efficiency of pigs with human skeletal muscle at this critical phase of product development. Achievement of milestones and product development will provide a platform for the Phase II grant application.